Development of LNS8801 for cutaneous melanoma patients who cannot tolerate immunotherapy

Project Summary:
Although recent advances in immune and targeted therapies have dramatically improved outcomes
for many patients with advanced cancer, durable responses are achieved in only a minority of patients,
and treatment is frequently limited by significant side effects. These side effects include immune-related
adverse events (irAEs), which often prevent patients from receiving further immunotherapeutic agents
to treat their disease. There is an urgent need to identify new therapeutic targets and efficacious
pharmacologic agents that selectively engage them. Orally deliverable, well-tolerated, and easily
synthesized small molecule cancer therapeutics that work in combination with existing standard-of-care
drugs are especially desired. Recent work by us and others established that many cancer types are
inhibited by nonclassical estrogen signaling through a widely expressed surface receptor called G
protein-coupled estrogen receptor (GPER). Linnaeus has used Small Business Technology Transfer
(STTR) and Small Business Innovation Research (SBIR) awards (R41/R44 CA228695), along with
venture capital funding, to advance a GPER agonist called LNS8801 to human trials. Preclinical work
has established that (1) LNS8801 has potent antitumor effects across a wide range of malignancies
and that this activity depends on GPER expression in the tumor cells; (2) LNS8801 has beneficial
combinatorial effects with targeted therapies, chemotherapies, and immunotherapies; and (3) LNS8801
has a large safety window in rats and dogs. Linnaeus also developed an orally bioavailable and
manufacturable formulation of LNS8801. Together, this work enabled us to receive clearance of an
Investigational New Drug Application as well as Fast Track designation from the FDA in anti-PD1
refractory melanoma; Orphan Designation from the FDA in cutaneous melanoma; initiate a multisite
phase 1 clinical trial (NCT04130516) and complete dose escalation at 10 cancer centers in the United
States. LNS8801 has proven safe and well tolerated at all dose levels and the mechanism of action has
been validated in humans. We also identified that consensus GPER, lacking a hypofunctional germline
variant, serves as predictive biomarker. LNS8801 has demonstrated benefit in patients with multiple
cancer types, particularly in cutaneous melanoma patients with prior irAEs. The purpose of this Phase II
proposal is to expand upon the preliminary clinical data and complete a proof-of-concept study of
LNS8801 in melanoma patients with prior irAEs. Success in this single arm cohort will define metrics
and assumptions necessary to conduct a future randomized controlled trial to support registration in this
setting, which represents a large unmet need.

Public health relevance
Project Narrative: Although recent advances in immune and targeted therapies have dramatically improved outcomes for many patients with advanced cancer, a large subset of patients cannot tolerate immunotherapy. This project is designed to complete the critical steps necessary to advance a novel, promising therapeutic for cutaneous melanoma patients who cannot tolerate immunotherapy to the next phases of human trials and potential future commercialization.